From genetic basis to mechanisms for Heart Failure

SUMMARY
Heart failure (HF) is a global epidemic affecting millions of people worldwide. Despite improved medications and
device therapies for the management of HF in clinical practice, the morbidity and mortality of HF remain strikingly
high. In the United States, HF prevalence is projected to increase by over 40% till 2030. There is an urgent need
to identify novel HF therapies that are more effective and targeted. There are many known risk factors for HF
including age, HTN, cardiovascular disease (CVD), diabetes, and genetics. Genome-wide association studies
(GWAS) have started to identify common genetic risk loci associated with HF. In the largest HF GWAS to date
completed in 2022, 47 loci were identified. This number is anticipated to increase quickly in the upcoming years.
While genetic discoveries hold promise to discover new targets for therapeutic development, a major challenge
with GWAS for HF is identifying the causative genes and in turn the underlying mechanisms through which these
genes modulate the risk for HF. There is a critical unmet need to accelerate functional interpretation of genes
associated with HF in disease-relevant cell type to identify genes or pathways that are causal for HF. To address
this challenge, we have applied two complementary, high throughput assays, Cell Painting and Perturb-seq to
link genes associated with HF to discrete molecular and cellular phenotypes. To accomplish this goal, we
developed and optimized CARDIO (Cardiomyocyte Analysis using Robust Cell Painting Imaging and Output),
an assay that allows high-content morphological profiling of human pluripotent stem cell derived CMs (hPSC-
CMs). We applied our CARDIO approach to a CRISPR knockout assay of 37 genes selected from a GWAS of
cardiac contractile function. We identified a novel role for two genes, YWHAE and HSPB7 with divergent effects
in CM morphology and function. Functional validation using engineered heart tissues (EHTs) demonstrated
YWHAE knockout (KO) had a similar functional profile as titin KO. In contrast, loss of HSPB7 induced a
hypertrophic phenotype and restored contractile function in a titin model of DCM. our approach demonstrates
that the combination of morphological profiling with functional assessment can identify novel genes involved in
heart failure at scale, and potentially identify biological mechanisms for therapeutic development. In this proposal,
we will leverage our novel functional genomic approach to investigate the roles of all GWAS genes associated
HF. We will analyze the impact of loss of the genes at the GWAS loci for HF using a combination of CARDIO or
imaging based morphological profiling (Aim 1) and Perturb-seq or transcriptional profiling (Aim 2). Finally, we will
seek to validate leading candidates in engineered heart tissues (Aim 3). These studies enable us to ascertain
relationships between HF risk genes and cellular phenotypes at scale, providing a framework for rapid validation
of genetic discoveries to disease mechanisms, which will generate testable hypotheses for future investigations
using animal models or human cardiac organoids.

Public health relevance
Narrative Despite major advancement in clinical interventions for heart failure, its prevalence remains high with a seemingly unstoppable trend, paralleled to high mortality with a 10-year survival rate of 27% in severe cases, urging for new therapies that are more effective and targeted. Human genetic studies of heart failure have begun to discovery many genes that can increase the risk of HF, which brings hope in finding new and more targeted therapies to prevent and treat HF. Here we plan to use two cutting-edge technologies that can study hundreds of genes in millions of cells at the same time, which will speed up the process from genetic discoveries to cell functions and causes of HF, increasing the success rate of new drug targets in clinical development.